Metabolic cytometry for in-line process analysis

Project Summary/Abstract
Gene therapy uses genes to prevent and/or treat acquired disorders and inherited genetic diseases.
Recently, the intensive investigation of human genes and related diseases has improved the capability of gene
therapy as a promising future therapy that can significantly increase life expectancy for millions of patients
suffering from incurable diseases. This promise has accelerated the exponential growth in the field of gene
therapy. However, the clinical potential of gene therapy remains largely unleashed, mainly due to the limited
biomanufacturing capacity of gene delivery products for clinical and commercial use. Manufacturing of gene
therapeutic biologics involves harvesting viral vectors in mammalian cell cultures which are highly complex
and difficult to control. The lack of understanding and control of the viral production processes has led to
manufacturing challenges including low productivity, instability of cell lines, high levels of impurities, and
difficult scalability with consistent product quality. Therefore, new biomanufacturing analytical technologies
are critically needed to improve the understanding of the bioprocess dynamics and to support development of
robust and efficient biomanufacturing processes.
Physical Sciences Inc. (PSI), in collaboration with the University of Massachusetts Lowell (UML) proposes
to develop a novel biomanufacturing process analytical technology tool that enables in-line, continuous
measurement of the metabolism of host cells in bioreactors for the large-scale manufacturing of therapeutic
viral vectors. A novel metabolic cytometry sensor probe that measures the autofluorescence of intracellular
metabolites will be used for real-time assessment of cellular-level redox metabolic state. An innovative
spatially and temporally confined spectroscopy approach is used to efficiently differentiate fluorescence
signals of intracellular metabolites from the nonspecific light background, achieving high specificity
measurement of cellular physiology. During the Phase I program, a prototype fiber-based fluorescence
cytometry probe system will be fabricated and evaluated, demonstrating the capability of the real-time
metabolic measurement during bioreactor operations for viral vector production. Technology maturation and
application demonstrations in additional bioreactors using a variety of culture organisms will be performed
during the Phase II program. Successful development of this technology will contribute to significant
improvement in the understanding and control of bioprocesses for large-scale manufacturing of viral vector
products for gene therapy.

Public health relevance
Project Narrative The focus of this project is to develop a metabolic sensing probe system for controlling and monitoring cells in biopharmaceutical processes for production of gene therapy drugs. The capability of real-time and in-line measurements of cellular metabolism will promote the understanding and control of cell-culture bioprocesses, and thus improve the yield and support large-scale production of gene delivery products for clinical use.